Epidemiologic Determinants of Cardiac Structure and Function in Rural Residents: RURAL ECHO

ABSTRACT
Rural dwelling adults in the US South suffer disproportionate cardiovascular disease (CVD) burden and
mortality. The Appalachia and Mississippi Delta (AMD) regions are particularly at risk, embedded in the stroke,
heart attack and heart failure (HF) mortality belts, where the determinants are multifactorial. Echocardiography
is an ideal methodology to study CVD and determine high risk imaging phenotypes for incident heart failure
owing to its ability to noninvasively assess cardiac structure and function simultaneously. Due to the excess of
CVD in the AMD region, we therefore expect a high prevalence of abnormal cardiac structure and function
among rural adults, but this has not been explicitly shown. The NHLBI-funded Risk Underlying Rural Areas
Longitudinal (RURAL) cohort study, by assessing a broad array of phenotypic, biologic, and social
determinants of health represents a unique, cost-effective opportunity to implement a study to fill the gaps
described, reduce excess CVD burden, and achieve health equity for all Americans. The long-term goal of this
proposal is to understand the burden of adverse cardiac remodeling in the absence of symptoms (i.e., Stage B
HF) in the AMD region and factors contributing to it so that interventions during subclinical disease states may
avert clinical HF later in life. The overall objectives of this application are to apply in-depth echocardiographic
phenotyping to the entire RURAL cohort and combine these echo data with the broad array of data acquired in
RURAL to identify those factors which selectively amplify or mitigate HF risk. Using the infrastructure of the
parent study’s mobile examination unit (MEU) – ‘a clinic on wheels’ – we will perform echocardiography on all
participants at baseline to characterize cardiac structure and function using a novel artificial-intelligence (AI)
echo approach. Our central hypothesis is that there is a significant burden of Stage B HF, which is associated
with exposures spanning multiple domains and which can be delineated by integrating the multimodality
imaging on the MEU. We will achieve our objectives through these specific aims: (Aim 1) Use AI Echo and
meticulous core lab analysis to extensively characterize cardiac structure and function in RURAL; (Aim 2)
Determine associations of AI Echo findings with traditional biologic risk factors and comorbidities, with an
exploratory sub-Aim to determine associations between Stage B HF and social determinants of health; and
(Aim 3) To interrogate mechanisms of Stage B HF by determining relationships between echo-based imaging
biomarkers, CV calcifications, adiposity and CV risk. The proposed study will provide the largest and most
comprehensive echocardiographic dataset focused on rural adults that untangles the relative importance of the
association between biologic and social factors on Stage B HF and incorporates advanced methodology to
discover sub-phenotypes of Stage B HF based on multimodality imaging. RURAL Echo promises to yield new
knowledge on rural CV health that is highly relevant to individual and US public health.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because cardiovascular disease is a dire health concern for rural dwelling adults in the US who are among the most resource-limited. As a consequence of the work proposed, we expect to identify the determinants of differences in cardiac structure and function in rural America and their relationship to subclinical cardiovascular disease, considering a broad view of the determinants of health. The project is relevant to the part of the NIH’s and NHLBI’s missions that pertain to scientific inquiry to improve health in rural America and reduce health disparities.